Cellular Aging in a Yeast Model System

Mitochondria have long been implicated in aging. Most research linking this organelle to aging has stressed the deleterious effects of ROS generated by mitochondria during the course of aging, often hinting at the self-accelerating aspects of this phenomenon. However, it has become clear over the past decade that compensatory cell responses can attenuate the consequences of mitochondrial dysfunction occurring during aging. One of these adaptive responses is the retrograde response, which we demonstrated in yeast allows the cell to live as long as it does (14). This mechanism is now known to operate at the organism level in C. elegans as well (6-7), and evidence for its operation in human cells has been presented (8-10, 21). More recent work has pointed to mitochondrial quality control as an important device mitigating the accumulation of damage to mitochondria, either through intrinsic mechanisms (19-20, 22) or through mitophagy (23). The significance of this quality control for maintenance of age asymmetry between mother and daughter yeast cells is clear (19-20, 24), and it has implications for stem cell aging. The convergence of the retrograde response and mitochondrial quality control and evidence that sphingolipid signaling is involved are exciting new developments (25-26) (Fig. 14).